Career Development Program

The purpose of the Career Development Program (CDP) is to identify and train outstanding investigators who are committed to pursuing a career in translational skin cancer research. The program will primarily assist junior faculty in their career development, but more established investigators interested in refocusing their research efforts in melanoma/skin cancer may also be considered. Women and underrepresented minorities will be strongly encouraged to participate. The team of distinguished clinicians, educators and researchers will ensure implementation of the specific aims of this program which are as follows: Specific aim 1: To identify and select translational research investigators who will develop independent research careers in melanoma and/or skin cancer. Specific aim 2: To provide Career Development Awardees with formal training and mentorship from both the clinical and laboratory perspectives in order to establish successful independent careers in translational research. We require that award recipients be active in SPORE functions, use the SPORE Core resource, and provide formal written progress reports. Within the context of the CDP, we have established high standards and expectations of the research mentors and a structured, formalized program of mentorship for the CDP awardees. The program measures success by resulting publications, resulting funding, and career advancement and ultimately independent careers in translational research. We have an outstanding talent pool and an effective training and mentorship program which will result in an exceptional group of skin cancer researchers.

Public health relevance
The Career Development Program of the Penn/Wistar SPORE in Skin Cancer will prepare the next generation of translational investigators in melanoma and skin cancer.